C-H Bond Functionalization in Organic Synthesis

DESCRIPTION (provided by applicant): This proposal describes the development of general and selective Pd-catalyzed methods for the ligand-directed conversion of unactivated arene and alkane carbon-hydrogen bonds into new functional groups. Aims 1 and 2 focus on exploring new methods for C-H bond fluorination and trifluoromethylation, utilizing readily available and inexpensive fluoride and trifluoromethyl starting materials. A key objective is to identify novel (and potentially broadly applicable) reactivity modes for the Pd-catalyzed introduction of fluorinated groups into organic molecules. Aim 3 seeks to develop methods that use readily available dioxygen as the terminal oxidant for converting C-H bonds into diverse functional groups. Aim 4 focuses on developing widely applicable asymmetric catalytic C-H functionalization reactions. All of these aims will be tackled by taking advantage of the Sanford group's expertise in new reaction development/optimization, in detailed mechanistic investigations, and in the synthesis/characterization of reactive organopalladium intermediates. The reactions developed herein will find application in the synthesis/diversification of pharmaceutical candidates, natural products, positron emission tomography (PET) imaging agents, and biological probes. PUBLIC HEALTH RELEVANCE: The proposed work focuses on developing novel chemical reactions that use metal catalysts to convert readily available carbon-hydrogen bonds into more valuable functional groups in a single step. These reactions will result in faster and more environmentally benign routes to therapeutic agents for the treatment of human disease.

Public health relevance
The proposed work focuses on developing novel chemical reactions that use metal catalysts to convert readily available carbon-hydrogen bonds into more valuable functional groups in a single step. These reactions will result in faster and more environmentally benign routes to therapeutic agents for the treatment of human disease.